CLASS II GENES-STRUCTURE, ORGANIZATION, EXPRESSION

We propose to clone the entire I regions from BALB/c and AKR mice. We will identify, sequence and determine the organization of all class II genes with the I region. We will transfer class II genes into mouse L cells and normal bone marrow derived cells by DNA indicated gene transfer. We will study the DNA elements which control the expression of class II genes in the model mouse L cell system and normal hematopoietic cells. The class II genes will be altered by in vitro mutagenesis and their expression and functions studied after appropriate gene transfer experiments.